Innovative Detection of Alzheimer's Disease in Rural Uganda (IDARU)

PROJECT ABSTRACT
Despite an aging population with high prevalence of risk factors for cognitive impairment, scalable, accessible,
and accurate tools to detect cognitive impairment and Alzheimer’s disease (AD) in sub-Saharan Africa (SSA)
are lacking. Recently developed plasma biomarkers (phosphorylated tau, P-Tau181; neurofilament light chain,
NfL; glial fibrillary acidic protein, GFAP) and a brief digital cognitive assessment (Brain Health Assessment,
BHA) are promising tools to expand access to AD diagnostic screening in SSA. However, these tools have not
previously been evaluated in SSA populations. Additionally, the influence of HIV infection and the performance
of these tools to detect cognitive impairment and AD in people living with HIV (PLWH) are unknown. The
overarching goal of this administrative supplement is to validate the use of these novel plasma biomarkers
and an adapted BHA as screening tools to detect cognitive impairment, a defining feature of AD, in a rural
Ugandan population with a high burden of HIV infection. The central hypothesis is that plasma biomarkers
and the BHA will detect and classify cognitive impairment in a rural SSA cohort with high validity in both PLWH
and HIV-uninfected (HIV-) individuals, and that they will be promising tools for non-specialists to advance AD
diagnosis in this setting. The project fits squarely within the goals of the parent study (R01 AG059504), a
prospective cohort study of older-aged (>48 years-old) adults in rural Uganda including 300 PLWH on chronic
antiretroviral therapy and 300 HIV- individuals that aims to determine the trajectory of aging-related morbidity
and quality of life in this population. In specific aim 1 we will add measurement of plasma biomarkers (P-
Tau181, NfL, GFAP), and assess their performance in discriminating cognitive impairment, defined by
reference-standard neuropsychological testing, in the total cohort and in PLWH compared to HIV- individuals.
In specific aim 2 we will first translate and adapt the BHA using mixed methods. To accomplish this, the BHA
will be adapted using bilingual experts, local focus groups, and participant interviews, and then tested for
feasibility. After adaptation, the BHA will be administered to study participants, concurrent and discriminant
validity will be estimated, and performance will be determined in detecting cognitive impairment compared to
reference-standard neuropsychological testing in rural Uganda. The proposal is responsive to the Notice of
Special Interest by expanding the parent study to include a focus on AD detection tools, and it fits within the
scope of the parent study by including AD-relevant measures as determinants of aging-related morbidity and
quality of life in this population. Successful completion of this proposal is relevant to AD by expanding the
reach and generalizability of promising AD diagnostic screening tools to high-risk and low-resource populations
in SSA and in PLWH. Data from this project will form the basis of an NIH R01 grant to formally assess the most
promising biomarkers and tools in clinical practice in this setting.

Public health relevance
PROJECT NARRATIVE The proposed research will significantly advance the field of AD diagnostics by adapting and evaluating innovative and scalable AD detection tools to populations in SSA by leveraging an NIH R01-funded cohort study focused on aging and quality of life among people with HIV. This work will extend the reach of promising methods for large-scale AD diagnostic screening to diverse, high-need, and under-represented populations, and include capacity building in AD screening and detection in Uganda.